Intracellular Trafficking of DNA for Gene Therapy

Under almost all conditions using any method, the levels of gene transfer to any cell or tissue are low because
many barriers exist for the efficient delivery of genes to cells. The primary goal of our laboratory is to identify
and overcome the intracellular barriers to promote effective gene delivery and therapy. Exogenous viral or non-
viral DNA must cross the plasma membrane, travel through the cytoplasm and the cytoskeletal networks, cross
the nuclear envelope, localize to specific regions within the nucleus, and be transcribed in order for gene
therapy to be successful. We have shown that once in the cytoplasm, plasmids carrying DNA nuclear targeting
sequences (DTS) that are required for nuclear import in non-dividing cells rapidly associate with transcription
factors that mediate movement along microtubules and across the nuclear envelope. NF-kB is one such factor
that binds to several ubiquitously active DTSs and is required for DNA nuclear import, but in the cytoplasm it is
maintained in a sequestered state, unable to bind DNA. The question then is how is NF-kB activated to bind to
plasmids and mediate their cytoskeletal movement and nuclear import? In the case of NF-kB, a major pathway
for its activation is through a set of cytoplasmic dsDNA sensors, such as cGAS-STING, that are part of the
innate immune system and drive inflammatory responses. When dsDNA binds to cGAS, signaling cascades
are initiated that result in activation of key pro-inflammatory transcription factors (including NF-kB) and
ultimately production of pro-inflammatory cytokines. Thus, a major focus in the gene therapy space has been
to block activation of these sensors to reduce inflammation. However, we have observed that when cGAS is
silenced, cytoplasmically injected plasmids fail to traffic to the nucleus. We hypothesize that limited activation
of one or more of these sensors is actually needed for low level activation of key transcription factors in order
to facilitate DNA nuclear import in non-dividing cells. If we can find ways to limit sensor activation, but not
abolish it, this will allow for enhanced gene delivery with limited accompanying inflammation. We have also
spent considerable effort detailing the distribution of plasmids inside the nucleus and have found that the
subnuclear mislocalization of plasmids can affect their transcriptional activity. We have found that plasmids
localize to discrete transcriptional domains within the nucleus based on the type of promoter (Pol I, Pol II, or
Pol III) they carry and that when two different promoter types are placed on one plasmid, not only is the
intranuclear distribution of the DNA different that either promoter type alone, but transgene expression is
significantly reduced. We will dissect the pathways used for DNA movement within the nucleus and exploit
them to improve transgene expression based on the subnuclear localization of the transfected DNA. Our
specific aims are to (1) determine whether cytosolic dsDNA sensors are required for DNA nuclear import; (2)
evaluate whether residence time of DNA in the cytoplasm affects sensor activation and transfection efficiency;
and (3) characterize how subnuclear organization affects exogenous DNA expression.

Public health relevance
PROJECT NARRATIVE Many barriers exist for the efficient delivery of therapeutic genes to cells, animals, and patients for effective treatment of disease. Our work will discover what these barriers are, how they work, and how they can be overcome in order to improve DNA delivery and gene therapy.